Eliminating Ischemic Spinal Cord Injury and Paralysis after Aortic Aneurysm Surgery

Project Summary/Abstract
Each year, 24,000 new cases of thoracoabdominal aortic aneurysms (TAAA) are diagnosed in the United States.
The aging population, poor dietary habits, and smoking lead to a higher incidence of cardiovascular disease that
contributes to an increasing incidence of aortic aneurysms (AA) that are repaired surgically either through open
chest repair (OR) or thoracic endovascular aortic repair (TEVAR). Both repairs can lead to paraplegia, the most
feared and devastating complication of the surgery, which significantly worsens the quality of life and lifespan of
the patient.1-8 The rate of paraplegia after OR is 9.2-20% while the rate after TEVAR is 15-17%1,7-10,14-18. The
global market size for aortic aneurysms in 2018 was $2.5 billion with an expected compound annual growth rate
of 8.6% for 2019-2026.19 Paraplegia can cost over $2.3 million over the patient’s lifetime.20 Therefore, eliminating
paraplegia after both methods of AA repair represents an extreme urgency as well as an enormous challenge.
Little progress has been made since the first aortic repair surgery resulting in paralysis, likely reflecting the lack
of spinal cord (SC) tissue availability from patients and the lack of large animal models of TEVAR. Therefore,
new, innovative approaches are needed to make substantial progress in the field. Paraplegia after aortic repair
is a “man-made” pathology and occurs in a controlled medical environment, thus prevention is feasible in a
clinical setting. Because AA patients are admitted to the hospital one day before surgery, an unprecedented
opportunity exists to collect their blood, urine, and cerebrospinal fluid (CSF) to study the molecular malfunction
leading to paraplegia after surgery. The current understanding is that the SC injury caused by OR vs TEVAR are
distinct, heightening the need for specific therapeutic interventions to prevent paraplegia. It is hypothesized that
SC injury after OR vs TEVAR are two different pathologies that will require specific, independent considerations.
The first objective of this proposed conference is to discuss potential mechanisms on what can be done to
address the problem of paralysis after AA repair surgery, build up collaboration teams, generate new, innovative
ideas in specific areas of research aimed at preventing SC injury, and bring together physicians, academia, and
industry to solve this problem. At the end of the conference, a clear road map will be anticipated of the potential
strategies that will be taken from the clinical side and the basic research side to solve the problem. Discussions
will focus on the worldwide clinical perspective of AA surgical repair, recent progress in the prevention of
paraplegia, and future development of more effective clinical and research strategic plans to define the goal and
the plan needed to eliminate paraplegia. The second objective of the conference is to establish a national,
multicenter biobank with locations throughout the country that will store blood, CSF, and urine of paralyzed and
non-paralyzed patients after AA surgery that will be critical for understanding the molecular mechanisms causing
paralysis after either OR or TEVAR. Only with a better understanding of the molecular malfunctions leading to
paraplegia after AA repair will we be able to design future therapeutic prevention and treatment.

Public health relevance
Project Narrative Paraplegia is the most feared and devastating complication of aortic aneurysm repair surgery and current interventions have not reduced the incidence of paraplegia. A conference focused on eliminating ischemic spinal cord injury after the surgery will establish a clear road map of the potential strategies taken by clinicians and basic scientists to address this problem. The newly established collaborations will be the first step to bring together clinicians, scientists, and industry to create a national biofluid bank with the aim of developing potential strategies that need to be taken to develop therapeutics to eliminate paraplegia after aortic aneurysm surgery.